Acquisition of a Luxendo MuVi Light Sheet Microscope for the University of Rochester Light Microscopy Shared Resource Laboratories

ABSTRACT
This proposal seeks to obtain a Luxendo MuVi Light Sheet Microscope (LSM) with an
environmental control unit to be housed in the Light Microscopy Shared Resource Labs (SRLs)
of the University of Rochester Medical Center (URMC) as a shared equipment jointly supported
by the Multiphoton and Analytical Imaging Center (MAGIC) and the Center for Advanced Light
Microscopy and Nanoscopy (CALMN). This microscope would greatly expand and enhance the
imaging capabilities of both imaging centers to fulfill the increasing needs of fast three-
dimensional imaging of delicate live specimens as well as large cleared tissues from the diverse
user groups. Nowadays, researchers are interested in a more complete picture of their studied
models with higher degrees of multiplexing and throughput, while our current imaging systems
are insufficient to fully capture the three-dimensional characteristics of samples in fast and gentle
manners. Bringing in the LSM technique will significantly benefit many current health-related
research programs at URMC, which include studies on Influenza, CAR-T therapy, COVID-19,
Spinal Cord Injury, Autism etc., by significantly improving the spatial and temporal imaging
capabilities. The technological breakthroughs using light sheet microscopy will advance those
health-related research with better understandings of the intricate dynamics and structures of
cells within living and intact specimens.
High resolution fluorescence imaging has proven an invaluable and central tool for the
advancement of biomedical discoveries. The URMC Light Microscopy SRLs have seen a rapid
growth in the last three years with the join of two experienced directors introducing three new
cutting-edge imaging instruments that have greatly enhanced the community’s funded research
activities. Acquisition of a light sheet microscope will add new impetus to establishing a state-of-
the-art comprehensive imaging resource at the URMC and the upstate New York that will
continuously provide scientists new avenues for bearing on fundamental questions pertaining to
human diseases. Additionally, by leveraging the local data and computational resources, the Light
Microscopy SRLs will maximize the impact of the light sheet microscopy technique that can be
widely adopted by various research programs to further promote and advance biological
discoveries.

Public health relevance
PROJECT NARRATIVE Microscopic imaging is increasingly a powerful tool for understanding the complex processes within biological systems. Light Sheet Microscope is a cutting-edge equipment that can greatly facilitate the rapid collection of images over large sample volumes. Access to this new technique will immediately and dramatically enhance the scope of the URMC research, especially in the critical areas involving human lung development and disease studies, cancer therapy development, environmental neurotoxins discoveries and Autism Spectrum Disorders research, ultimately pushing forward to improve public health broadly.